Psychiatric research infrastructure for intervention and implementation in India (PRIIIA)

7. Abstract
With over 1.3 billion people, India faces enormous health challenges, particularly for neuropsychiatric
care. There are fewer than 7,000 psychiatrists or neurologists. India’s training infrastructure for research in
psychiatric intervention and implementation is also rudimentary, hampering innovative solutions for these
problems. To address the challenges, we have provided individually mentored hands-on research and
didactic training to over 59 trainees. The majority are women; 7 became department chairs and they have
published over 78 peer reviewed papers. Thanks to a multiplier effect of trainees-turned-trainers, we have
garnered over $ 5 million in research grants and initiated ‘south-south’ co-operation with Egyptian
colleagues. Over 20 years, we have attained our targets and gained momentum.
Our current D43 is focused on intervention research-based training in schizophrenia, principally cognitive
dysfunctions (2014-9). In this competing renewal we seek broader, accelerated impact through interlinked
extensions of our current work, each extension enhancing the next: (i) We will attain broader impact by
continuing hands on training for novel interventions in cognitive dysfunctions spanning psychiatric disorders
and post-stroke patients, relying on NIMH Research Domain Criteria. (ii) To enable real world impact for
interventions, we will add implementation research training based on the Consolidated Framework for
Implementation Research, addressing delivery of evidence-based care, creating processes for successful
interventions, and identifying constructs associated with local challenges and successes. (iii) We will expand
our hub building work by continuing ongoing work in Delhi and targeting 3 new academic and non-
governmental organizations; the latter serve particularly deprived communities. (iv) We will promote health
policy advocacy to the Government of India. Our overarching goal is a cadre of neuropsychiatric health
researchers who will conduct novel research, train future researchers, and influence health policy in India.
Our training will rely on multi-disciplinary Indian and overseas mentors to provide medium-term (6
months) or long-term research-based training (1-3 years) to 40 professionals. We will add neurologists to
our current training for starting and mid-level mental health professionals and new medical graduates. For
all trainees, the essential selection criterion will be a trainee-generated research idea relevant to our
themes. Implementing their ideas will be the goal of our individualized mentor-based training, supplemented
by flexible didactic course work. To enhance sustainability, we will reprise and expand our successful
‘grantathons’ designed to help trainees win research funds, problem solve for individual research and
address hub level issues. Inducting prior trainees as training faculty will produce a cascading effect. In sum,
we propose an innovative, flexible, multi-site ‘without walls’ capacity building program for training high
caliber, ethical researchers and for establishing hubs in India, relying on seasoned training faculty.

Public health relevance
8. Project Narrative Mental disorders cause severe burden across the world, particularly in low and middle-income countries. Our ongoing research will be used as the foundation for training highly motivated mental and neurological health professionals in India, which has over 1.3 billion citizens and enormous health problems. Our proposal fulfills key goals of the Fogarty International Center, the National Institute of Mental Health and the National Institute for Neurological disorders and Stroke; it will enhance treatment research for mental disorders and thus could also help US citizens.